Plan to Enhance Diversity

PROJECT SUMMARY/ABSTRACT
The Perlmutter Cancer Center at NYU Langone Health (PCC) recognizes that achieving diversity of its
membership and leadership is not only a moral imperative, but is necessary to maximize progress in cancer
prevention and therapy and thereby reduce the cancer burden of an increasingly diverse America. We are
committed to developing a workforce that “looks like the community we serve”, a goal that requires a sustained,
multi-level, and long-term commitment to develop the leadership potential of current faculty, identify and recruit
a diverse cohort of new trainees and faculty, and build a large pipeline of talented younger individuals who will
become our colleagues and leaders of the future. The new PCC Diversity, Equity, and Inclusion Core (DEIC)
was established to fulfill this commitment by developing an explicit plan to achieve these objectives and monitor
progress towards reaching our goals. The mission of DEIC is to engage in measurable actions that ensure that
PCC membership and leadership reflect the diversity of the population that we serve, with the ultimate goal of
eliminating disparities in the burden of cancer. DEIC is directed by PCC member Joseph Ravenell MD, MS,
Associate Professor of Population Health and Medicine, Associate Dean of Diversity & Inclusion, and a nationally
recognized leader in health and cancer disparities research. He is aided by Assistant Director Michelle Lightfoot,
MD, MPH, whose research interest is in health disparities in gynecologic oncology. The Specific Aims of DEIC
are: 1) to enhance the diversity of PCC leadership to include groups nationally underrepresented in the research
workforce. 2) to expand the diversity of PCC membership and workforce to reflect the diversity of the population
served by PCC, and 3) to increase diversity in the pipeline of future PCC members and workforce through
mentorship and training of students, trainees, and allied health professionals. Because diversity, equity, and
inclusion are critical to best cancer care and science, DEIC is essential to the PCC mission.